URSODEOXYCHLORIC ACID IN CYSTIC FIBROSIS ASSOCIATED LIVER DISEASE

This study proposes that ursodeoxycholic acid (URSO), administered orally daily, will improve the clinical outcome of cystic fibrosis (CF) patients with associated liver disease.